Role of Myristate and Sphingolipids on Intestinal ER Stress and Lipid Metabolism

Diets high in saturated fat have been implicated in disturbing intestinal homeostasis via multiple mechanisms;
however, the contribution of specific saturated fatty acids (SFAs) is largely unknown. Therefore, the goal of this
proposal is to examine the effects of specific dietary fatty acids (FAs) on sphingolipid metabolism and their
influence on intestinal pathobiology. Specifically, we aim to define the role of ceramide generating enzymes,
ceramide synthase (CerS) 5 and 6, in endoplasmic reticulum (ER) stress, inflammation, and lipid metabolism in
the intestines. Excess SFAs and a subsequent increase in ceramide generation induce ER stress in multiple
tissues. Biopsy samples from inflammatory bowel disease (IBD) patients exhibited dysregulation of sphingolipid
enzymes and increased activation of all three ER stress pathways; however, whether a relationship exists
between the two is only beginning to be elucidated. In the intestines we and others have implicated CerS as
regulators of lipid metabolism and ER stress. Canonically, ER stress is triggered by accumulation of mis-folded
proteins leading to activation of effector proteins IRE1α, PERK, and ATF6. Activation of these pathways halts
generation of new proteins, leads to degradation of mRNA and proteins, and if left unresolved leads to
inflammation and apoptosis. IRE1α activation has been implicated in regulating sphingolipid enzymes and other
lipid metabolic proteins, such as stearoyl-CoA desaturase 1 (SCD1). Although there have been a few
investigations into the role of SCD1 in intestinal inflammation and colon cancer; there is contention in the
literature on whether SCD1 is protective or detrimental. Individually ER stress, sphingolipids, and SCD1 have
been implicated in IBD and CRC; but the interplay of these factors in intestinal biology is not well understood.
Much of the literature examining the effects of a high fat diets (HFDs) has focused primarily on palmitate, a C16
SFA found in red meat and processed foods. However, we have previously shown that treatment with myristate,
a C14 SFA rich in milk-fat based diets, increased activation of IRE1α in a CerS5/6-dependent manner in rat small
intestinal epithelial cells (IEC6). Our current work extends these findings in human colon epithelial cells (HCECs).
In HCECs chemical inhibition of all six CerS isoforms suppressed myristate-induced ER stress however,
knockdown of CerS5/6 exacerbated ER stress. Our novel findings led us to the hypothesis that loss of CerS5/6
reduces SCD1 protein levels both basally and after myristate treatment in an IRE1a-dependent manner. To this
end we propose the following specific aims:
Specific Aim 1: Define the role of CerS5/6 in milk-fat diet induced IRE1α activation in intestinal biology in vivo.
Specific Aim 2: Elucidate the mechanism of CerS5/6 regulation on SCD1 in intestinal biology.

Public health relevance
PROJECT NARRATIVE High fat diets are a major risk factor for inflammatory bowel disease via multiple mechanisms. Much of the literature examining the impact of saturated fatty acids has focused on palmitate; however, the contribution of other saturated fatty acids is largely unknown. The proposed research plan will elucidate the impact of different dietary fatty acids, using carefully formulated high fat diets, and the role of ceramide synthase 5/6 on endoplasmic reticulum stress and lipid metabolism on intestinal biology.